The Role of Formins In Regulating Multicellular Mechanics During Tissue Stratification

? DESCRIPTION (provided by applicant): This research addresses a fundamental question in epithelial biology: What determines whether epithelial sheets exist as monolayers, like the intestine or kidney ductules, or multilayered structures like the skin and cornea? Despite an abundance of genetic data, a gap remains in our understanding of how molecular determinants physically elicit or prevent stratification. Prior work indicates that Rho-GTPases and downstream myosin contraction activators support proper stratified tissue architecture. Rho-GTPases also reshape the network upon which myosin operates by activating formins, a protein family responsible for nucleating and elongating cytoskeletal actin filaments. Nonetheless, the contribution of formin-mediated actin architecture to tissue stratification has received little attention. I hypothesize that cadherins exploit formins to ensure that cell contacts engage contractile machinery via linear actin conduits, prone to snapping, and, in turn, conducive to basal layer exit.

Public health relevance
PUBLIC HEALTH RELEVANCE: Disrupted tissue architecture is a hallmark of numerous inherited and acquired diseases. In particular, this research is relevant to understanding aberrant development, healing and function in diseases affecting stratified epithelia like the skin cornea and esophagus. It also pertains to development of stratified masses from simple epithelia, a step in the progression of numerous cancers.